Identification of cognitive decline and dementia: Prediction by everyday driving behaviors and physiological responses

Abstract
Per FOA PA-20-272, the Parent Abstract is included in the Research Strategy section of this Administrative
Supplement.

Public health relevance
Narrative Per FOA PA-20-272, a narrative is not required for this Administrative Supplement, as it is the same as the Parent grant.